Tubuloglomerular feedback response in AKI to CKD transition

Acute kidney injury (AKI) is associated with higher risk of developing chronic kidney disease (CKD), which is
a growing health problem afflicting over 37 million US adults with cost over $80 billion every year. However, the
underlying mechanisms, especially the risk factors that contribute to development into CKD for people with AKI
has not been fully elucidated. Additionally
, no specific therapy is available in prevention of AKI to CKD transition.
Therefore, further understanding the pathophysiological mechanisms is essential for identification of new
therapeutic targets for prevention of AKI to CKD transition.
Decrease in GFR is a hallmark for AKI and CKD. TGF response is one of important mechanisms that regulate
GFR. NOS1β is the primary splice variant and contributes to most of the NO generation by the macula densa.
Recently, several studies from our laboratory demonstrated the decisive role of macula densa NOS1β-modulated
TGF response in the long-term control of GFR, sodium excretion and blood pressure. However, whether the
macula densa NOS1β-modulated TGF responsiveness plays a significant role in transition to CKD from AKI is
unknown.
In the present proposal, we propose to test our central hypothesis that following renal IRI, NOS1β expression
and activity in the macula densa are decreased, which enhance TGF responsiveness and decrease GFR,
thereby promoting transition to CKD. Rescue of macula densa NOS1 prevents AKI to CKD transition.

Public health relevance
Acute kidney injury (AKI) is associated with higher risk of developing chronic kidney disease (CKD). In the present proposal, we will examine the significance of macula densa NOS1 and NOS1-modulated tubuloglomerular feedback in AKI to CKD transition.